Technology Dev Core

ABSTRACT
While populating the technology pipeline is a task in which all the cores are engaged, the
Technology Development (TD) core's mission is critically dependent upon maintaining an input
pipeline of technologies with a potential value as point of care (POC) technologies. As a
continuing effort in this proposal, TD core will continue to seek out research facilities, small
start-up companies and large diagnostics companies whose technology could be applied to the
rapid analysis of nucleic acid or protein targets. The TD core will inform them about the
commercial opportunities afforded by the market for sexually transmitted infections (STI) POCT
and about the types of support for STI test development that the Johns Hopkins Center for Point
of Care Tests (POCT ) for sexually transmitted diseases (STD) offers. The TD core will manage
solicitations to fund new sub awards (at least three per year (years 2-5) from birth to completion.
The underlying goal of these sub awards is to fund technologies which if successful in their
development will have a significant impact on the delivery of health care in a variety of
operational environments. The Johns Hopkins University Applied Physics Laboratory (JHU APL)
has demonstrated success in this area over the past 5 years with over 80% of the companies
awarded tactical $50K sub awards receiving follow on funding in excess of $100K to sustain
development of their POCT. In a new task which arose from lessons learned during the last 5
year funding period, the TD core will take a more active role in technology development by
applying JHU APL's extensive expertise in systems engineering (SE). SE is a method
commonly used to understand and improve the outcomes of highly complex systems when they
are required to interact with each other. Applying techniques such as failure mode evaluation
analysis (FMEA) and the Delphi methods, JHU APL will apply SE techniques to assist with
resolution of Go/No Go transitions in the Center's pipeline and for forecasting the impact of
POCT adoption under various operational conditions respectively. Finally, the TD core will offer
system engineering review (SER) to organizations building STI POCT. JHU APL will administer
a second type of solicitation to competitively award SE reviews. Industry surveys conducted in
the last 5 years indicate that a majority of POCT community would participate in this type of
activity if offered at no cost to them. SERs would be a new resource offered by the Center to the
POCT community.